ADVANCED FUNCTIONAL PHENOTYPING OF PANCREATIC ISLETS USING THE BIOREP PERIFUSION SYSTEM V5

PROJECT SUMMARY
Perifusion is the gold standard for physiological assessment of islets of Langerhans, the functional units
of the pancreas consisting of various endocrine cell types such as -cells which secrete insulin, -cells
which secrete glucagon, and -cells which secrete somatostatin. The Islet Cell Biology Core (ICBC) at
the University of Pennsylvania, established in 1997, is a resource that provides functional phenotyping
of islets for NIH-funded investigators both locally and throughout the nation. Perifusion is a cornerstone
service of the ICBC that offers users dynamic measurements of insulin, glucagon, and somatostatin
secretion from isolated islets in response to various secretagogues. Recently, Biorep released the
PERI5, a state-of-the-art perifusion system combining the latest technological advancements in
protocol capability, throughput, reproducibility, and usability. The main feature of the PERI5 is a
disposable 12x12 microfluidic manifold which allows for parallel perifusion of up to 12 independent
perifusion chambers, representing a significant improvement in the technology that promises greater
reliability and reproducibility of perifusion experiments. The ICBC is well-positioned to leverage the
PERI5 system to provide the highest quality perifusion data to the diabetes research community at the
University of Pennsylvania and across the United States, in line with the University of Pennsylvania
Perelman School of Medicine's mission to “advance knowledge and improve health through research.”

Public health relevance
PROJECT NARRATIVE Functional assessment of the pancreatic islets by perifusion is fundamental to developing novel methods to treat or prevent diabetes. Our proposal for the Biorep PERI5 perifusion system promises to accelerate diabetes research by allowing the Islet Cell Biology Core at the University of Pennsylvania to make state-of-the-art perifusion technology available to NIH-funded diabetes researchers who employ perifusion techniques to study pancreatic islets.